Using Implementation Interventions and Peer Recovery Support to Improve Opioid Treatment Outcomes in Community Supervision

Project Summary/Abstract
This is a supplement proposal to capitalize on the Jails and Prisons Opioid Project (JPOP) website, to
collaborate with the JCOIN web site and ecosystem to enhance impact of both. The ultimate goal is to increase
the availability of medications for opioid use disorder (MOUD) for people caught up in, and transitioning out of
prisons and jails, to reduce overdose deaths and other deleterious effects of ongoing illicit opioid use.
Medications for opioid use disorder (MOUD) are the standard of care in the community. There are currently
three FDA-approved medications that comprise MOUD: methadone, buprenorphine, and naltrexone. Despite
the endorsement of the World Health Organization, the National Academies, as well as the National Institute
on Drug Abuse of the use of MOUD to treat people incarcerated with opioid use disorder, few of the roughly
5,000 correctional facilities across the United States offer it. The present project will expand on the data and
resources related to MOUD availability and implementation that currently exist on the Jail and Prison Opioid
Project (JPOP) website, and connect the website to the JCOIN platform to enhance uptake and utilization of
the resources of both sites. JCOIN has an excellent network of researchers, a tremendous amount of relevant
data being collected, has outstanding technical assistance and peer-to-peer capabilities as well as
dissemination capacity. This proposal aims to merge JPOP with the JCOIN initiatives to enhance the
capabilities of both.

Public health relevance
Narrative The present project will expand on the data and resources related to MOUD availability and implementation that currently exist on the Jail and Prison Opioid Project (JPOP) website, and connect the website to the JCOIN platform to enhance uptake and utilization of the resources of both sites. JCOIN has an excellent network of researchers, a tremendous amount of relevant data being collected, has outstanding technical assistance and peer-to-peer capabilities as well as dissemination capacity. This proposal aims to merge JPOP with the JCOIN initiatives to enhance the capabilities of both.